Lactobacillus rhamnosus: A Novel Probiotic Therapy for treating Alcohol Use Disorder

This application is a proposal for a mentored clinical research award (K23) that will enable Dr. Vatsalya
Vatsalya to continue to develop his skills in clinical research; specifically, identifying new therapeutic targets for
the treatment of patients with alcohol use disorder (AUD) and concomitant moderate alcohol associated
hepatitis (AH). AUD represents one of the leading causes of preventable deaths in the United States and
efforts are in progress to identify new interventions. Emerging animal and human research suggest that
Lactobacillus rhamnosus GG (LGG), a probiotic, is involved in the restoration of a normal gut microbiome,
attenuating gut dysfunction and lowering endotoxemia and inflammation. Dr. Vatsalya’s overall goal is to
complete mentored research and transition to independent research. He also plans to successfully obtain a
tenure-track faculty position that will allow him to fully establish his own independent research program. Dr.
Vatsalya’s training goals are to: (1) broaden his conceptual knowledge in researching the
neuropharmacological mechanisms in AUD; (2) enhance his experience with human studies in the field of AUD
and alcohol associated liver disease (ALD); (3) improve his methodological skills in order to conduct effective
large-scale trials; and (4) improve his grant- and publication-writing skills. These training goals will be achieved
through: (a) the resources available at the University of Louisville; (b) the high quality of mentorship provided
by his mentor and the mentor committee; (c) focused training and clinical experiences; and (d) the proposed
research project. During the award period, Dr. Vatsalya’s goals are to: (1) complete the K23 research and
develop preliminary data to conduct a larger bedside-to-bench study using the results and skills obtained
during the K23 grant; and (2) apply for an NIAAA investigator-initiated (R01) grant based on the preliminary
outcomes. Alcohol consumption is associated with altered microbiome and gut dysfunction, increased gut
permeability, systemic endotoxemia (gut-derived bacterial products in the circulation), and proinflammatory
activity. The gut dysfunction observed with heavy drinking has also been associated with the development of
liver injury and inflammation observed in ALD. The research component of Dr. Vatsalya’s application will
investigate if LGG can restore normal gut function, reduce gut permeability and proinflammatory activity,
thereby improving the symptomology of concomitant AUD and ALD. The proposed research project extends
Dr. Vatsalya’s previous work on the pharmacological treatment of AUD and on the role of LGG in mediating the
gut-brain axis that could be expanded to identifying new interventional-mechanistic targets in AUD.

Public health relevance
PROJECT NARRATIVE Heavy and chronic alcohol drinking is a major medical and public health problem that is frequently diagnosed as alcohol use disorder (AUD). Existing FDA approved treatment options for AUD have limited efficacy and adverse effects; thus, alcohol associated organ injury especially liver injury is a commonly observed comorbidity. This project may lead to the use of Lactobacillus rhamnosus GG (LGG) as a novel effective therapy for AUD and concomitant moderate alcohol associated hepatitis (AH).